NEW TASK ORDER AWARD ALCOHOL CUE HUMAN LABORATORY STUDY TESTING APREMILAST. CONTRACTOR TO SERVE AS A CLINICAL RESEARCH SITE FOR A MULTIPLE-SITE CLINICAL TRIAL TO TEST APREMILAST FOR THE TREATMENT OF

The purpose of this Task Order is to serve as one of three clinical research sites as part of a multiple-site clinical trial to test and evaluate in Alcohol Use Disorder treatment seeking individuals the efficacy and safety of Apremilast in an alcohol cue human laboratory paradigm. This Task Order requirement involves recruitment, enrollment and retention of human subjects for clinical trial participation, Good Clinical Practice testing of compounds, compound storage, administration of study medication to study participants, data collection, and collaboration/coordination of activities with the current NIAAA Contract Research Organization (CRO)/Clinical Coordinating Center contractor for the NIAAA Medications Development Clinical Investigations Network under the direction of the NIAAA.